Control of Photoreceptor Metabolism

Project Summary/Abstract
A general understanding of the metabolic needs of photoreceptors could lead to broadly
applicable therapeutic strategies to treat retinas stressed by diverse genetic and
environmental factors. With that in mind, we have been investigating the fundamental
nature of energy metabolism in the retina and the retinal pigment epithelium (RPE).
Photoreceptor metabolism is limited by the availability of nutrients from the RPE.
Evidence indicates that the retina and RPE function together as a network of
metabolically specialized and interdependent cells. We hypothesize that a deficiency in
any component of that network could lead to retinal degeneration as part of the failure of
the entire metabolic ecosystem. Our recent findings support this hypothesis. We have
proposed a model in which the flow of glucose from the choroidal blood through the RPE
to the retina is enhanced by lactate produced by glycolysis in photoreceptors. Lactate
not only fuels the RPE, but it also can influence the differentiation state of RPE cells.
These observations are the basis for the specific aims of this proposal. The first aim will
explore ways to enhance the flow of glucose across the RPE. The second aim will
investigate how lactate influences differentiation of RPE cells. This project will identify
ways to enhance the flow of glucose across the RPE to the retina. Our findings can be
used to design therapeutic approaches that make photoreceptors in an eye more robust
and resistant to genetic and environmental factors that normally would cause
photoreceptor degeneration.
.

Public health relevance
Project Narrative The retina and the retinal pigment epithelium each have unique and specialized metabolic functions. Our recent findings show that the specialized metabolic features of these tissues contribute to an essential symbiotic metabolic relationship between the retina and RPE. Findings from the experiments in this proposal will expedite the understanding of underlying causes of many forms of blindness and the decline of vision that occurs with aging.